A pilot randomized controlled trial to determine the biochemical effect, safety and patient reported outcomes of copper supplementation in cirrhosis

Project Summary: The overall premise of this research is that copper (Cu) status is a
previously under-recognized and potentially modifiable risk factor in cirrhosis, the most
advanced stage of chronic liver disease. In the United States, chronic liver disease affects 4.5
million people and accounts for over 41,000 deaths per year. Cirrhosis requires high rates of
healthcare utilization compared to other diseases with an annual cost of approximately $21
billion. Malnutrition is one of the few modifiable factors that have been associated with poor
prognosis. Current guidelines in nutritional intervention focus on protein and calorie intake,
and give little consideration to trace elements, which have wide ranging physiological effects. Cu
deficiency in the absence of liver disease compromises Cu dependent enzyme functions which
can cause iron overload, tissue fibrosis and susceptibility to infections – pathologies also
observed in cirrhosis. Our recent large cohort study identified Cu deficient cirrhosis patients, as
defined by low serum Cu concentrations, had higher infection rates and a 3.4-fold increased risk
of death compared to patients with normal Cu levels. Our preliminary findings and the well-
established importance of Cu in human health raise several important questions: Does reduced
circulating Cu, the standard definition of Cu deficiency in the general population, similarly
reflect a deficiency state in cirrhosis? Is the higher infection and mortality risk observed among
patients with low serum Cu mediated by Cu dependent enzymes and immune cells? Is reduced
circulating Cu a secondary response in cirrhosis, therefore should be “left alone,” or should
patients receive Cu supplementation in order to improve functional Cu store and its associated
physiological functions? In an attempt to answer these questions, we designed a pilot
randomized, placebo-controlled, crossover trial to determine the effect of Cu supplementation
on Cu dependent biochemical changes, patient safety and patient reported outcomes.

Public health relevance
Project Narrative This work, at the crosswalk of clinical and basic science, is relevant to the NIH mission because chronic liver disease affects 4.5 million adults and accounts for over 50,000 deaths each year in the United States. Our preliminary data indicate that deficiency in copper, an essential trace metal with wide-ranging physiological effects, is an independent and potentially modifiable risk factor in advanced liver disease, or cirrhosis of diverse origins. In response to the new NIH Initiative on Precision Nutrition in disease management and PA- 23-086 for small R01s for clinical trials, the current proposal aims to determine biochemical changes associated with copper status, safety as well as patient reported outcomes in cirrhosis patients who receive copper supplementation.